CHEETAH Center for the Structural Biology of HIV Infection, Restriction, and Viral Dynamics

CORE SUMMARY
Our Administrative Core will support CHEETAH Center missions by providing enabling administrative services that will
increase the productivity, integration, efficiency and management of all of our Scientific Projects and Cores, and will
maximize impact by supporting high-quality public outreach and scientific education programs. Our Administrative Core
has three Components, which will organize CHEETAH Center Personnel and Structure (Component 1), Manage the Center
(Component 2), and support our efforts in Public Outreach, Scientific Education, and Molecular Animations (Component
3).

Public health relevance
CORE NARRATIVE Our Administrative Core will support CHEETAH Center missions by providing enabling administrative services that will increase the productivity, integration, efficiency and management of all of our Scientific Projects and Cores, and will maximize impact by supporting high-quality public outreach and scientific education programs.